WORKSHOP ON THE NIH CONSENSUS DEVELOPMENT PROCESS

The objective of this acquisition is to convene workshop to examine consensus development procedures used in medical decision making. This will be accomplished by convening a meeting to review the NIH consensus development process and to develop recommendations for its improvements. The analysis will focus on the following process elements: topic selection; the role, size and composition of the committee; the formulation of the agenda; the selection and preparation of speakers; the presentation and synthesis of data; the development of consensus; the dynamics of the committee; and the preparation of the initial and final consensus statements.